Paired inhibition of falciparum merozoite invasion

The ongoing, indeed once again increasing, burden of malaria is well-recognized, as is the steadfast threat of
drug resistance that drives discovery efforts for new antimalarials. Drug combinations to enhance efficacy and
to thwart the emergence of resistance are now considered a requirement for antimalarial therapy. Elegant
genetic and inhibitor studies have revealed the sequential multistep process of merozoite invasion into
erythrocytes, and have identified as essential the linkage of highly conserved reticulocyte-like binding protein 5
(Rh5) to basigin, its red cell membrane protein receptor. This proposal explores the consequences of combining
human anti-Rh5 monoclonal antibodies with small molecule inhibitors, against asexual falciparum malaria
parasites in vitro. Selected monoclonals will target Rh5 epitope communities that are known to inhibit parasite
growth. Small molecule choices will include representative inhibitors for every phase of merozoite invasion.
Combinations will be evaluated for additivity, synergy or antagonism. Findings from these experiments will
guide further studies.

Public health relevance
Malaria is an infectious disease that continues to pose a major threat to public health. This laboratory-based project will explore the idea of combining multiple therapies simultaneously against malaria parasites, in hopes of identifying highly susceptible target pairs suitable for further study.